Admin Core

PROJECT SUMMARY/ABSTRACT: CORE A
The overarching theme of this program project renewal entitled “Pathobiology of Neurodegeneration in
C9ORF72 Repeat Expansion” is to determine the mechanisms by which C9orf72 repeat expansions cause
amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), and identify novel therapeutic targets
and biomarkers in order to improve the diagnosis of and prognosis for patients suffering from c9ALS/FTD.
Core A will facilitate these goals by providing scientific and fiscal oversight. Core A will be responsible for
managing fiscal responsibilities for the program project, ensuring ethical and responsible conduct of research,
providing scientific direction and accountability, and reporting progress to the NIH and to the public. To assure
the success of this research proposal, Core A will also foster a multidisciplinary program that advances
research, generates valuable biological resources, and promotes education. To accomplish its goals, Core A
will pursue the following specific aims. Specific Aim 1: Provide administrative structure and fiscal oversight for
the program project grant. Specific Aim 2: Organize regular meetings of the Executive Committee to assist in
the scientific administration and to facilitate integration and continuing progress on research aims. Specific
Aim 3: Establish an External Advisory Committee, conduct annual meetings, and report progress to the
NINDS. Specific Aim 4: Ensure that the clinical research conforms to the standards of the ethical conduct of
research and the safety of human subjects. Specific Aim 5: Report progress to NIH and ensure compliance
with the NIH Public Access policy. Specific Aim 6: Promote education on ALS and related disorders, and
encourage P01 scientists and clinicians to participate in patient and caregiver support groups.